Core--Cyclotron & radiochemistry facility

D.I.I. Introduction: The Cyclotron and Radiochemistry facility is a Specialized Resource component of both the UCLA-ICMIC and the UCLA Department of Energy Molecular Medicine program. Our history with the DoE program predates the initiation of the NCI ICMIC, extending back for over three decades. The prime objective of the Cyclotron and Radiochemistry Specialized Resource is to foster all radiopharmaceutical needs of UCLA-ICMIC and UCLA-DoE investigators, and to serve other UCLA research projects that complement these research programs.